Nanoparticle-mediated Histotripsy (NMH) for Noninvasive and Targeted Ablation of Metastatic Breast Cancer

PROJECT SUMMARY
Breast cancer is the most common malignancy among women, with almost 1.7 million patients diagnosed
annually. Although promising treatment options are currently available, metastatic disease remains a significant
challenge. Indeed, the vast majority of breast cancer deaths are a direct consequence of metastasis and no cure
is available once metastatic disease has developed. Thus, new treatment strategies are needed to eliminate
mortality associated with metastatic breast cancer. This proposal is focused on the development of
nanoparticle-mediated histotripsy (NMH) as a non-invasive and targeted ablation method for the
treatment of multi-focal breast tumors. Histotripsy is a non-invasive, non-ionizing, and non-thermal ultrasound
ablation method that destroys tissue through the precise control of acoustic cavitation generated by high-
pressure (>25-30 MPa) pulses. Histotripsy does not have the limitations of thermal ablation and can produce
consistent ablation, even in near vessels. Additional benefits of histotripsy include high precision and real-time
imaging guidance. However, although histotripsy shows promise as an improved ablation method for the
treatment of primary tumors, this treatment method requires high ultrasound pressures and remains limited to
tumors that can be identified and imaged prior to treatment, which is often not feasible in metastatic breast cancer
patients with multiple tumor nodules. To address this need, our team recently invented NMH as a targeted
ablation approach for treating multi-focal tumors by combining perfluorohexane (PFH) nanoparticles
with histotripsy. NMH takes advantage of the significantly reduced cavitation threshold of these particles,
allowing for histotripsy to be selectively generated only in regions containing the particles. In this proposal, we
develop NMH for the selective ablation of metastatic breast tumors. In Aim 1 we engineer and characterize PFH
“nanocones” with a smaller size (~50nm), higher stability, and functionalized targeting capabilities compared to
our previously tested particles. Aim 2 will test the in vitro feasibility of these PFH “nanocones” for targeting and
selectively ablating breast cancer cells in a tissue engineered 3D breast cancer model. Aim 3 will investigate the
in vivo feasibility of NMH for the targeted ablation of metastatic breast tumors in an orthotopic mouse model.
Together, these studies are expected to demonstrate the feasibility of NMH for multi-focal tumor ablation, which
is essential to establishing the potential of this new technology. If successful, this work will lay the foundation for
NMH as a targeted multi-focal cancer therapy capable of significantly improving the standard of care for cancer
patients by increasing targeting specificity and treating tumors too small to detect by imaging.

Public health relevance
PROJECT NARRATIVE This Project will develop nanoparticle-mediated histotripsy (NMH) as a novel non-invasive method for the selective ablation of multi-focal breast tumors. Studies will be conducted to test the in vitro and in vivo feasibility of NMH in relevant breast cancer models using targeted acoustically active perfluorohexane “nanocones” that are capable of selectively binding to breast cancer cells. These studies will provide essential pre-clinical data that is needed to demonstrate the potential of NMH for treating metastatic breast cancer.